Democratically Designed Optimal Dosing Regimens To Combat Overuse

Background: Most newly-approved drugs – especially precision medicines – are administered at excessively
high dosages. The 21st Century Cures Act and 2023 FDA Appropriations Act attempts to address this by recom-
mending post-marketing studies that test lower drug dosages. These trials are rarely conducted due to perverse
incentives (less drug reduces industry revenue), patient reluctance (risk that lower doses may be worse), and
perception of limited demand for them (given optimal dosing regimens’ slow adoption). Overcoming these issues
requires (1) deeper understanding of prescribers’ evidence requirements for using optimal dosing regimens, (2)
development of new trial designs that test optimal dosing regimens, and (3) making the trial design paradigm
more accessible and accountable to patients and payers. Response-adaptive randomized trials use interim re-
sults to change the probabilities with which participants are assigned to a study’s different treatment arms. These
designs are ideal for post-marketing dose optimization studies because they reduce the risk of Veterans receiv-
ing doses that are too low, yet we know very little about how these trial designs would be accepted or adopted.
Significance: Optimizing high-risk precision medicine dosages will reduce harms to Veterans, increase Veter-
ans’ access to care, and improve VHA care’s value – helping to address major HSR&D priorities. This CDA
engages Veterans in research design to ensure ORD-funded research aligns with Veterans’ values, increase Vet-
erans’ access to innovative studies, and build community among Veterans with cancer – all ORD strategic priorities.
Innovation & Impact: This CDA reverses canonical drug development. It builds qualitative methods by using role
play-enhanced focus groups (Aim 1) and simulated clinical trials to inform deliberative democracy (Aim 3). It uses
a novel quantitative method (response-adaptive randomized optimization) to optimize drug dose (Aim 2).
Specific Aims: Aim 1: Assess prescribers’ barriers to accepting the results of different dose optimization study
designs using role-play-enhanced focus groups of oncologists. Aim 1 identifies (1) prescriber knowledge gaps
and preferences and (2) barriers to be addressed in a subsequent implementation intervention (Year 3 IIR). Aim
2: Develop and evaluate in simulated clinical trials response-adaptive randomized trial designs that address
stakeholders’ optimal dosing regimen preferences. Aim 2 enables these new trial designs to be evaluated by
Veterans. Aim 3: Engage Veteran stakeholders in clinical trial co-creation by conducting (3A) an informed con-
sent discussion of a hypothetical trial and (3B) democratic deliberation (DD) of dose optimization trials’ tradeoffs.
Methodology: Aim 1: Role-play-enhanced focus groups of a nationally representative sample of VHA and non-
VHA oncologists. Groups will role-play an advisory panel tasked with evaluating an optimal dosing regimen,
which will uncover oncologists’ authentic evidence requirements for dose optimization trials and their barriers to
implementing optimized regimens. Evidence requirements will inform the trials developed and evaluated in Aim
2. Aim 2: Simulations, conducted in R, of ~1000 distinct trials (combinations of study design, sample size, and
efficacy), with the intent of identifying trial designs that identify optimal dosage while minimizing risks to subjects
(i.e., receiving too low a dose) and society (i.e., by falsely declaring a suboptimal dose to be efficacious). Aim 3:
In 3A, we conduct individual interviews with Veterans with cancer and their caregiver(s) discussing a hypothetical
dose optimization study, conducted through the lens of informed consent. Participants in 3A will be invited to join
3B, which will consist of a Citizen Jury DD sessions seeking Veteran consensus on 1) how optimization trial
designs can best align with Veterans’ values and 2) how best to approach informed consent for these studies.
Next Steps/Implementation: (1) Enhance optimal dosing regimen adoption in VHA through targeted implemen-
tation intervention (Year 3 IIR; Aim 1 as preliminary data) and (2) enhance Veteran access and safety and VHA
value by proposing the CDA’s end trial product as a VA-based dose optimization platform (Year 5 IIR). PI’s
presentations to standing regulatory, administrative, and research collaborators will enhance VA’s global impact.

Public health relevance
Providing all Veterans’ with access to safe, high-quality, high-value care is VA’s top priority. Giving too much of a toxic drug can harm the Veterans who receive the drug – and it wastes resources that could have helped another Veteran. To safely and efficiently serve as many Veterans as possible, VA doctors need to know the smallest amount of drug needed to achieve the best results. Typical drug company-sponsored clinical trials do not give this information, so VA has to figure it out – except nobody knows the best way to figure it out. By bringing together Veterans with cancer, cancer doctors (oncologists), statistics experts, and health services re- searchers, we can develop new types of trials that find the smallest dosage, in turn increasing Veterans’ safety and VA’s efficiency. In this project, Veterans take a leading role in designing future cancer clinical trials, ensuring that future trials align with their values while still generating data that are useful for Veterans and oncologists. The findings will guide clinical practice changes, providing safer, higher-quality, higher-value care to all Veterans.